Regulation of directed neuroblast migration by the ECM and MAB-5/Hox

Project Summary
Directed cell migration is a fundamental morphogenetic mechanism used by animals to build tissues and
organs. For example, neural crest cells migrate long distances in the embryo and develop into a plethora of cell
types, including the entire peripheral nervous system. In C. elegans, the Q cells are bilateral neuroblasts born
in the posterior-lateral region of the animal that undergo left-right asymmetric migration. Initially, QR on the
right protrudes and migrates anteriorly, and QL on the left posteriorly. This initial directed migration is regulated
by the receptor molecules UNC-40/DCC and PTP-3/LAR, which drive posterior migration. A left-right (L/R)
asymmetry in the Q cells results in UNC-40 and PTP-3 being active in QL but not QR, leading to posterior
versus anterior migration, respectively. The second phase of migration relies on Wnt signaling and begins after
the first Q cell division. QL and descendants encounter a posterior EGL-20/Wnt signal that drives expression of
the MAB-5/Hox transcription factor, whereas QR and descendants do not express MAB-5. Further posterior
migration of the QL descendants requires MAB-5, which is both necessary and sufficient for posterior Q
descendant migration. QL and QR undergo an identical pattern of cell division, migration and cell death to
generate three neurons apiece. The phases of Q migration are independent (e.g. in mab-5 mutants, QL initial
migration to the posterior is normal, but Q descendants then migrate anteriorly).
Our preliminary data indicate that an inherent L/R asymmetry in QL versus QR determines how these cells
respond to the extracellular matrix (ECM), which specifies anterior versus posterior migration. Specifically, the
Collagenα1XXIV molecule DPY-17 directs posterior migration. DPY-17 is expressed broadly throughout the
animal, as opposed to other ECM-related guidance cues (UNC-6/Netrin, SLT-1/Slit) expressed in specific
regions to direct migration. Possibly, the structure of the ECM itself provides anterior-posterior guidance
information to the Q cells, and UNC-40/DCC and PTP-3/LAR interpret this information. We will test this idea by
analyzing DPY-17 and other ECM components in initial Q migration. After initial migration, mab-5/Hox
expression in QL directs posterior migration. mab-5/Hox is a terminal selector gene which specifically controls
posterior migration and not other aspects of cell division, death, or neuronal differentiation. We will take a
functional-genomic approach to define a transcriptional cassette downstream of the MAB-5/Hox terminal
selector that directs posterior migration. This proposal utilizes a cutting-edge combination of techniques (e.g.
fluorescence-activated cell sorting (FACS) of C. elegans cells and RNA-seq), and leverages the strengths of
the C. elegans system in discovery science. It has the potential to significantly advance the goal of achieving a
detailed understanding of a simple developmental decision to migrate posteriorly versus anteriorly.
Mechanisms used by the Q cells might regulate directed cell migrations involved in neural crest and
neurodevelopmental disorders in humans.

Public health relevance
Project narrative The migration of neuroblasts and neurons is central to the formation of neural circuits and networks that underlie nervous system function. Knowledge of the molecular signaling pathways that regulate neuronal and neuroblast migration will be relevant to human neurodevelopmental disorders.